The Molecular Profile of Prostate Tumors in African-American Men

Previously, we generated gene expression profiles of primary prostate tumors resected from African-American and European-American patients. Analyzing the resulting dataset, we identified gene expression differences between African-American and European-American patients that portray the existence of a distinct tumor microenvironment for these two patient groups. Many of the differently expressed genes were immune-regulatory. These observations have been replicated by others. Perhaps most unexpected was the presence of a distinct interferon signature in many of the African-American tumors. As now shown by us, this signature is closely related to an interferon-related DNA damage resistance signature (IRDS) that predicts resistance to chemotherapy and radiation. Interestingly, IRDS has also been linked to the pro-metastatic epithelial to mesenchymal transition of cancer cells. Thus, IRDS may promote the metastatic process in certain circumstances. To further understand the possible origin of the detected immunobiological differences in tumors of African-American and European-American prostate cancer patients, we started with the evaluation of blood-based immune cell and inflammation marker profiles of African-American and European-American prostate cancer patients and age-matched population-based controls with a focus of immune cell subpopulations that have immune-regulatory functions in cancer biology. It was the hypothesis of this project that immune cell subpopulations that have immune-regulatory functions in cancer biology are different in abundance in these two population groups. This study did not find that any of the investigated immune cell subpopulations (myeloid-derived suppressor cells, T- and B-cell-derived suppressor cells, dendritic cell subpopulations and polarized macrophages) were different in abundance comparing the blood samples from African-American and European-American prostate cancer patients. In contrast, we observed that levels of the inflammation marker, c-reactive protein or CRP, were significantly higher in both African-American patients and controls when compared to European-American patients and controls, indicating the possible presence of a systemic low-grade inflammation in African-American cancer patients, and also healthy men. We recently observed that aspirin use significantly reduces the risk of aggressive prostate cancer in African-American men. Because of this observation, we will test if the tumor biology of prostate cancer patients who are regular aspirin users is different from patients who do not take aspirin. In addition, we are examining whether the development of the IRDS signature and systemic inflammation could be functionally linked to a germline variation that frequently occurs in men of African ancestry but is rather uncommon in men of European ancestry and encodes a novel interferon termed interferon lambda 4 (IFNL4 rs368234815-dG). Preliminary data show that patients with the dG allele, which is significantly more common in African than European populations, have an increased occurrence of IRDS. This finding has recently been published in Clinical Cancer Research (PMID:30012562). The presence of an interferon gene signature in prostate tumors also suggested a possible involvement of either a viral infection in disease pathology or the reactivation of endogenous retroviruses in the tumor microenvironment. This hypothesis was further supported by our finding that the interferon signature in prostate tumors coincides with a gene signature of retroviral activation. Currently, there is no evidence that a viral infection is a cause of prostate cancer, although a meta-analysis of 26 tissue-based case-control studies reported an association between human papillomavirus positivity and the disease. Additionally, RNASEL, a gene that protects against viral pathogens, may have an important tumor suppressor function in prostate cancer. Because of our observation that viral infection-related host factors are associated with prostate cancer in African-American men, we begun to study the relationship between viral infection history and the disease using a novel technology, termed VirScan. The aim of this study is to examine the viral infection history in African-American men, and how it relates to prostate cancer. We will also investigate the relationship between the IFNL4 dG genotype and viral infections, and whether there is an interaction between them in prostate cancer development and progression. A completed study linking sexual activity to prostate cancer supports the hypothesis that a viral infection may contribute to the risk of prostate cancer among carriers of the IFNL4 dG genotype (PMID:30456312). An alternative pathway that may lead to an interferon signature in prostate tumors is the aberrant expression of tumor-derived neo-antigens, which can elicit an immune response. For example, it was shown that therapy-induced alterations in DNA methylation can cause the expression of otherwise silenced endogenous retroviral sequences, resulting in an interferon response in tumors and enhanced sensitivity to immune therapy. The observation supports the hypothesis that changes in DNA accessibility can lead to increased neo-antigen presentation, linking DNA accessibility to neo-antigen expression and an immune response. DNA accessibility is largely controlled by the chromatin structure (e.g., open vs. condensed). We hypothesize that distinct chromatin accessibility signatures could be the underlying cause for the increased expression of endogenous retroviral sequences in tumors of African-American patients and the common occurrence of an interferon signature in them. To test this hypothesis, we will study differential DNase I hypersensitivity (DHS) in prostate tumors and cell lines of African-American and European-American men. DHS is an alternative measure of chromatin accessibility and generates chromatin accessibility signatures for cells or tissues. The ENCODE project has mapped all DHS sites, together with their gene expression and transcription factor binding (chip-seq data) profiles, on a whole genome scale for 125 diverse cell and tissue types. Using the ENCODE database, we can map regions of chromosome accessibility in prostate tumors to their known functions, and to gene expression and chip-seq data. As an alternative to DNase-seq, we may use the Assay for Transposase Accessible Chromatin with high throughput sequencing, termed ATAC-seq, which is a technology for fast and sensitive profiling of chromatin accessibility. Lastly, we have started the work in support of the DoD Impact award, W81XWH1810588 (PI Ambs), A Precision Medicine Study of How Inflammation May Underlie the Excessive Burden of Prostate Cancer in Men of African Ancestry. Here, 92 immune-inflammation marker and the fatty acid prolife of blood samples will be analyzed in NCI-Maryland (see ZIA BC 010499) and NCI-Ghana study participants (about 3000 in total) and will be linked to GWAS and survey data. The aim is to examine associations with prostate cancer, African ancestry, lifestyle factors, socioeconomic status, and medical history. We will also analyze cyclooxygenase 1/2 metabolites in urine samples from the NCI-Maryland studies and examine for differences between African-American and European-American men and for a linkage with prostate cancer, aspirin use, medical history, and lifestyle factors. We will link these data to tumor biology by studying gene expression profiles and the mutational spectrum (whole exome sequencing) of prostate tumors from the NCI-Maryland study and a cohort from Nigeria (PI Yates) that have paired blood immune marker profiles.